The role of vitamin K in knee osteoarthritis outcomes

PROJECT SUMMARY/ABSTRACT
Despite the tremendous public health burden of OA, trials have largely been negative to date and there are no
effective approved treatments that can prevent structural progression. There is increasing interest in refining the
phenotype of people enrolled into OA trials to better match the known mechanisms of the interventions to relevant
patients to increase likelihood of successfully detecting treatment effects. Vitamin K is a promising therapeutic
option in knee OA given its association with structural outcomes, and the high prevalence of inadequate dietary
vitamin K intake among older adults. Prior work has demonstrated associations between lower vitamin K levels
and cartilage loss on knee MRI. Whether the vitamin K-dependent matrix Gla protein (MGP), which functions to
inhibit bone and cartilage mineralization when activated, may provide insights into how vitamin K affects OA
structure is not known. Further, whether MGP could be used as a biomarker of vitamin K’s effects on structural
outcomes to potentially reduce trial durations merits investigation. Beyond the impact of lower vitamin K levels
on structural OA outcomes, an improved understanding of its impact on clinical outcomes, including pain and
physical function, is needed as vitamin K supplementation may be an effective intervention targeting both
symptoms and structure. Finally, although there is increasing interest in testing vitamin K supplementation in OA
trials, the appropriate form and dosing have not been determined, nor what therapeutic threshold needs to be
targeted to obtain anticipated beneficial effects. I will leverage data collected in the Multicenter Osteoarthritis
Study, including previously collected knee radiographs and MRIs and stored blood biospecimens to evaluate the
following: 1) blood thresholds of vitamin K associated with increased risk of structural OA outcomes (cartilage
damage, bone marrow lesions, and synovitis), and the role of MGP as an intermediate in this pathway to assess
its potential as a serum biomarker; 2) association of vitamin K levels and MGP on knee pain and physical function
in knee OA; and blood thresholds of vitamin K associated with increased risk of poor clinical outcomes. As a
third aim, I will perform a pilot trial testing different forms and dosing of vitamin K supplementation on plasma
levels of vitamin K and inactive MGP in older adults with knee OA. These proposed studies are innovative as
they will provide novel insights into the relationships between vitamin K levels and both structural and
symptomatic outcomes. The proposed research is significant as these insights would lay the foundation for
identifying an important phenotype (those with lower vitamin K levels) for testing a potential intervention (vitamin
K supplementation) for OA structure and/or symptom modification. This project will importantly provide the
necessary protected time, essential training, and mentorship to support my transition to becoming an
independent investigator focused on improving outcomes for patients with OA.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on understanding vitamin K insufficiency (a modifiable risk factor) in knee osteoarthritis, which is a common cause of disability among older adults worldwide. Insights from the proposed research would lay the foundation for identifying an important OA phenotype targetable for testing vitamin K supplementation leading to disease modification, providing an important breakthrough for this disease in which there are no proven effective disease-modifying therapies available to date. Thus, the proposed research is relevant to NIAMS’ mission to support research into the causes, treatment, and prevention of arthritis and musculoskeletal and skin diseases; and to support the training of basic and clinical scientists to carry out this research.